MECHANISM OF MUSCLE WASTING IN AGING

The primary goal of this study is to determine the effect of aging on muscl protein synthesis. The secondary goal is to determine whether this process s reversible by resistance training.